Computational Biology and Informatics Shared Resource

Computational Biology and Informatics Shared Resource: Summary/Abstract
The mission of the Computational Biology and Informatics Shared Resource (CBI) is to provide both
computational biology support and computational and data infrastructure to facilitate cutting-edge cancer-
related research at the HDFCCC. This shared resource includes resources of two cores presented in the
previous renewal: Computational Biology (CB) and Translational Informatics (TI).